PARALLEL TRANSMIT ARRAY FOR 7T MRI SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The proposed upgrade of the 7 Tesla imaging resource will substantially impact the fundamental understanding, early diagnosis, and development of novel therapies for host of human disease.